Virtual Care Strategies to Improve Participation in Cardiac Rehabilitation among Veterans

Background: Cardiac rehabilitation (CR) is a comprehensive secondary prevention program involving
exercise training, behavioral activation, and psychosocial support following cardiac events such as myocardial
infarction, coronary revascularization, valve replacement. Randomized clinical trials (RCT) have demonstrated
lower mortality and greater physical, mental, and social functioning in patients who participate in CR vs. usual
care. However, the long-term mortality benefit of CR is directly proportional to the number of sessions
completed, and less than half of Veterans who enroll in CR complete the recommended number of sessions.
Significance: Home-based CR (HBCR) is an alternative to traditional CR programs that has comparable
efficacy in improving morbidity/mortality and increases access to critical services. Improving participation in
home-based CR has been identified as a major priority by the National Director of Cardiology. We propose to
test a novel and easily scalable intervention to increase HBCR adherence and improve functional capacity/
physical activity in Veterans at risk for secondary cardiac events. This project addresses a major quality gap
and aligns closely with VHA Modernization priorities of: a) virtual care/telehealth utilization; b) digital
transformation; and c) MISSION Act implementation by offering high quality, easy to access care.
Innovation and Impact: There is major potential to improve Veteran engagement in CR by combining digital
coaching (d-Coaching) with existing VA-supported technologies. Our theory-based intervention targets a
critical component of successful CR engagement that is not available through traditional programs: virtual
social support through a social network. In addition, we propose to improve self-efficacy and self-regulation
through interactive digital multi-media education, personalized feedback, and motivation so that Veterans can
complete the prescribed HBCR program and maintain physical activity long-term. The innovative features
include: 1) the use of the VA-approved MOVN mobile app to deliver the d-Coaching intervention and provide
peer social networks; 2) interactive tailored messages via Annie text messaging to reinforce Veteran-centered
goals, learning, and support; and 3) optional participation in a Fitbit private group leaderboard.
Specific Aims: Aim 1: Determine the effect of the d-Coaching intervention on the number of completed HBCR
sessions over 3 months. Aim 2: Determine the effect of the d-Coaching intervention on: a) functional capacity
(6-minute walk test), b) physical activity (daily step counts, sedentary time), c) psychosocial outcomes
(depressive symptoms, quality of life), and d) clinical outcomes (HbA1C, lipids) and rehospitalization/
mortality. Aim 3: Determine the effect of the d-Coaching intervention on social cognitive factors of self-efficacy,
self-regulation, and perceived social support. Aim 3a: Evaluate the extent to which self-efficacy, self-regulation,
and perceived social support mediate the effect of the intervention on function and physical activity.
Methodology: The VA IMPACT (Improving self-Management of Physical Activity with Cardiac rehabilitation
Training through the digital coaching) RCT will evaluate the effects of HBCR alone (usual care) versus HBCR
+ d-Coaching, including a private social networking group, optimized Annie text messaging, VA Video
Connect, and connected devices (Fitbits). We will randomly assign 150 Veterans from 2 HBCR programs to a
3-month intervention with repeated-measures outcome assessments for 12 months. The addition of d-
Coaching to existing digital technologies will be operationalized by applying health technology to provide social
support, education, personalized feedback, and motivation for patients enrolled in HBCR.
Next Steps/Implementation: Leveraging digital technologies is advantageous because of their low cost,
scalability, availability across multiple settings (e.g., rural), potential for individual tailoring, and opportunities for
real-time modification. Assuming the proposed study demonstrates benefit for the d-Coaching intervention, we
plan to implement and disseminate it across all VA facilities with HBCR programs.

Public health relevance
Veterans who experience a significant cardiac event (surgery, stent placement, heart attack) qualify for cardiac rehabilitation, which is associated with clear benefits in improving health and survival. Unfortunately, enrollment and participation in cardiac rehabilitation is approximately 10%. Many VA sites use home-based cardiac rehabilitation in order to provide greater access to Veterans. There is major potential to improve Veteran engagement in home-based cardiac rehabilitation by using digital health technology in order to provide social support, which is a critical component for engagement. In our clinical trial, we will compare home-based cardiac rehabilitation alone (usual care) versus home-based cardiac rehabilitation plus digital coaching. Digital coaching is considered as providing social support, education, feedback, and motivation through a private social networking group and text messaging. We will examine group differences in cardiac rehabilitation participation, functional capacity, physical activity, psychosocial, clinical, and social cognitive outcomes.